BISMUTH SUBSALICYLATE VS ASPIRIN VS PLACEBO TREATMENT

To determine whether treatment with bismuth subsalicylate and/or aspirin will decrease the death rate among nursing home residents treated with antibiotics.